Training in Obesity Research

PROJECT SUMMARY
Obesity is rampant in the U.S. and has been acknowledged as a leading cause of death. Obesity has
been linked to diabetes, hypertension, cardiovascular disease, dementia, and cancer. Efforts to understand
and manage this complex disease have met with modest success such that obesity and particularly severe
obesity continues to grow in prevalence at an alarming rate in both adults and children. It is likely that research
which transcends traditional boundaries of research and focuses on transdisciplinary approaches to research
questions may provide the answers needed to conquer this grave threat to public health. This application is a
request for renewal funding for the Pennington Biomedical Research Center-LSU training program originally
titled “Obesity: From Genes to Man”. This T32 program which trains postdoctoral fellows was first funded in
2003, and successfully renewed in 2007 and 2012. The aim of this application, now titled “Training in Obesity
Research” is to train postdoctoral fellows in the complex interactions between genetic, molecular,
physiological, behavioral and population aspects of obesity. The objective of the Training in Obesity Research
T32 program is to prepare postdoctoral fellows to become productive research scientists capable of
establishing independent scientific careers in academia, governmental agencies, and in the private sector.
These junior scientists will further the efforts of the NIH to understand obesity and attenuate its impact on
public health. During their 2-3 years of training, the postdocs will be exposed to the model of team science and
will receive instruction in scientific writing, grant writing, methods to assure rigor and reproducibility of research,
and the use of big data and bioinformatics. The program will take advantage of the cutting-edge technologies
and the wide range of research efforts related to obesity available at Pennington Biomedical. This broad-
based, training program will enable trainees to acquire transdisciplinary research skills and write papers and
competitive grant proposals addressing important questions, which will move our science forward and help
them to develop into independent researchers. Pennington Biomedical is committed to postdoctoral research
training and sees this as inseparable from their goal of excellence in research. This application is requesting
five (5) additional years of funding for five (5) trainee positions per year.

Public health relevance
PROJECT NARRATIVE Obesity is a leading cause of death, and has been linked to diabetes, heart disease, dementia, and cancer. Transdisciplinary research which attempts to synthesize approaches from basic, clinical, and population science may find the answers needed to conquer this public health threat. The objective of this program is to train junior-level scientists to use the latest tools and methods in obesity research, while interacting with scientists of many disciplines to better understand and combat obesity.